Modulation of Neutrophil Function by Red Cell Exchange in SCD Patients

Project Summary/Abstract
Activated and hyper-reactive neutrophils play a significant role in sickle cell disease (SCD). Recent evidence
suggests that abnormally reactive neutrophils contribute to many of the thromboinflammatory complications of
SCD, including acute chest syndrome and stroke. To prevent these complications or to treat acute events, many
patients with SCD undergo a procedure called red cell exchange (RCE). RCE is an automated procedure which
removes the patient’s endogenous red cells containing abnormal hemoglobin S (HbS) and infuses healthy donor
red cells containing HbA. RCE is standard of care in both the inpatient and outpatient setting, as achievement
and/or maintenance of HbS < 20-30% has been shown to reduce the otherwise high incidence of recurrent stroke
and also leads to resolution of acute chest syndrome. However, whether RCE affects neutrophil activation and
hyper-reactivity, thereby contributing to its beneficial effect on SCD complications, is unknown. To answer this
question, as shown in preliminary data, we have begun to enroll a cohort of patients with SCD who undergo
chronic RCE in the outpatient setting. Our preliminary data support the hypothesis that RCE reduces neutrophil
hyper-reactivity, resulting in significantly attenuated degranulation responses to a range of agonists, including
bacterial ligands. Furthermore, we show that these changes in neutrophil reactivity may be due to the
presence/absence of circulating HbA/HbS. Based on the preliminary data presented in this application, we will
test the hypothesis that RCE, and the replacement of abnormal HbS red cells with normal HbA red cells,
modulates neutrophil reactivity and function. In Aim 1, we will comprehensively determine the effect of RCE on
neutrophil function and phenotype and establish the time course of changes in neutrophil function. As well, we
will perform a pilot study examining neutrophil function pre- and post-RCE in patients hospitalized with acute
chest syndrome to determine whether our findings are applicable during an acute inflammatory event. In Aim 2,
we will establish the multiple mechanisms whereby RCE modulates neutrophil reactivity. We will investigate 3
major pathways by which RCE may be modulating neutrophil function. Using artificially created admixtures of
HbA and HbS red cells as well as admixtures obtained from SCD patients pre/post RCE, we will examine
interactions between (1) neutrophil Siglec-9 and SS RBC glycophorin A, (2) neutrophils and phosphatidylserine
exposed on SS RBCs, and (3) neutrophils and SS RBC adhesion molecules. As well, we will establish the impact
of RCE on thromboinflammatory activity including heterotypic aggregate formation and markers of endothelial
damage. Together, these studies build on our novel observation that RCE modulates neutrophil function. The
overall goal of this proposal is to understand the effect of transfusion on neutrophil activation and to determine
if inhibition of neutrophil reactivity can be used as a functional endpoint to establish personalized therapeutic
targets for SCD patients. Findings from this proposal will guide future studies to identify functional biomarkers
for high risk patients and will provide additional biological insight into the emerging role of neutrophils in SCD.

Public health relevance
Project Narrative Patients with sickle cell disease often receive blood transfusions or undergo a procedure called red cell exchange, which removes abnormal sickle red cells and provides healthy donor red cells. We have found that transfusion and red cell exchange affects the reactivity and function of neutrophils, which are . In this application, we will determine how transfusion and red cell exchange affects neutrophil function in patients with sickle cell disease. increasingly implicated in the pathophysiology of sickle cell disease